Low-Cost High-Performance NIRS-SCOS Device for Non-Invasive Monitoring of Cerebral Blood Flow and Intracranial Pressure in Traumatic Brain Injury

Abstract
Monitoring intracranial pressure (ICP) and treating elevations in ICP to maintain adequate cerebral blood
flow (CBF), is the recommended standard of care following severe traumatic brain injury (TBI). ICP is measured
by a small pressure-sensitive probe inserted through the skull, with risk of intracranial hemorrhage and infection,
hence used only in comatose patients. The ability to monitor ICP non-invasively would improve global access to
ICP monitoring, allow for faster and more effective triage of trauma patients, extend ICP monitoring to patients
whose risk may be substantial but not enough to justify the invasive procedure. Transcranial Doppler ultrasound
(TCD), the current leading non-invasive alternative to invasive ICP monitors, is not sufficiently accurate, requires
specialized operators and is impractical for continuous monitoring. In this context, diffuse correlation
spectroscopy (DCS) a near-infrared diffuse optical method, has emerged as a promising alternative to estimate
ICP from the critical closing pressure (CrCP, the arterial blood pressure at which brain vessels collapse and
cerebral blood flow ceases) or the morphology of the pulsatile cerebral blood flow signal (pCBF). The main
barrier for widespread adoption of DCS for ICP measurements is the low signal to noise ratio (SNR) of currently
available technology, which limits source-detector separation to 2.5 cm, offering relatively low brain sensitivity
and strong scalp contamination, and requires pulse-gated averages of 50-60 cardiac cycles to extract clean
pCBF waveforms, compromising the morphological information. Building on our expertise and on our preliminary
results, we propose to develop a novel speckle contrast optical spectroscopy (SCOS) device, featuring pulsed-
laser sources and heterodyne detection, able to assess pCBF at 3.5 cm and 50 Hz with superior SNR (>100 x
gain over DCS). Moreover, we plan to integrate the SCOS device with our recently developed wearable near-
infrared spectroscopy (NIRS) device (FlexNIRS), which, by synergistically operating between SCOS camera
frames, will simultaneously measure pulsatile blood volume. As shown in our preliminary results and a recent
publication, the simultaneous measure of pulsatile blood flow and volume will allow separation of arterial inflow
and venous outflow, and further enhance pCBFi SNR and sampling rate, which, we hypothesize will improve ICP
estimation accuracy. Finally, the integration of SCOS and FlexNIRS will provide additional important biomarkers
to monitor brain health status on TBI patients, i.e., hemoglobin oxygenation, changes in cerebral blood flow,
hemoglobin concentration and oxygen consumption, cerebrovascular resistance, and cerebral autoregulation..
The successful realization of this state-of-the-art, non-invasive cerebral monitor will have a transformative role
in neurocritical care, especially in low resource and rural settings, by expanding access to ICP monitoring and
providing new monitoring indications to improve outcomes after TBI. Further, the prototype instrument developed
in this work will provide a strong basis for future clinical studies and translation into clinical practice.

Public health relevance
Narrative: In traumatic brain injury intracranial pressure (ICP) needs to be monitored to prevent secondary injury. Unfortunately, ICP is currently measured invasively and because of the complexity and risks of the procedure it is limited to most critically ill patients. We propose to develop a novel low-cost and high performances portable diffuse optical device able to accurately monitor ICP continuously and non-invasively. The ability to monitor ICP non-invasively would allow to extend monitoring past the critical condition, and monitor patients in ambulatory and emergency settings, allowing for faster and more effective triage of trauma patients.